NPETE's Community College Consortium for Health & Safety

The National Partnership for Environmental Technology Education, ME submits this proposal on
behalf of the Community College Consortium for Health and Safety Training (CCCHST) to provide convenient,
memorable, and cost-effective training for hazardous materials and waste workers engaged in waste treatment,
storage and disposal, hazardous waste generation, clean up and remedial action, emergency response and
hazardous materials transportation. CCCHST membership consists of community colleges partnered with
business and industry, universities, and CBOs offering a consistent and quality response to the national
training need for hazardous waste workers and emergency response personnel. In 2024, CCCHST included 119
organizations employing 178 instructors located in 29 states and two U.S. territories.
The goal of CCCHST is to make NIEHS-approved worker training nationally available through over 100
CCCHST organizations, whose instructors are prepared through a Train-the-Trainer model program, offering
hazardous materials instruction in nearly all states of the nation. CCCHST instructors, prepared by PETE, will
annually train a minimum 30,000 students, workers, and supervisors to protect themselves and their
communities from exposure to hazardous materials encountered during hazardous waste site cleanup,
Brownfields redevelopment, transportation of hazardous materials, and response to spills and releases of
hazardous materials, offering a minimum 300,000 contact hours of instruction each year.
Each year, PETE and Eastern Iowa Community Colleges (EICC), or another qualified CCCHST member,
will provide an intensive 5.5-day, hands-on Great Environmental Safety Trainers (GreatEST) Train-the-Trainer
Institute for up to 20 instructors entering membership in CCCHST, supplemented with Internet-supported
instructor training featuring a virtual waste site, and an optional 2.5-day, hands-on Industrial Spill Response
Train-the-Trainer. Annually, Refresher/Stayfresher training will be provided for all CCCHST instructors with
50 members supported with travel funds to attend the annual 2.5-day Refresher Conference.
PETE will also provide direct worker training for a minimum 600 Total Military Family personnel at
three (3) bases including Fort Riley (KS), Fort Sill (OK), Fort Carson (CO), and via Zoom nationally and
internationally for Veterans, soon-to-retire military personnel or family members who need OSHA
certifications to enhance employment opportunities. PETE and partner, Home Builders Institute, will track
veterans’ career paths.
PETE’s responsibilities include instructor recruitment; instructor authorization through Train-the-
Trainer Institutes and Refresher courses; military training, curriculum development; site visits for quality
assurance purposes; reporting numbers of students trained; website communication; working with the
Advisory Board and external evaluator to determine program effectiveness; and collaborating with NIEHS and
other NIEHS consortia to accomplish mutual goals and objectives.

Public health relevance
The goal of CCCHST is to make NIEHS-approved worker training nationally available through over 100 CCCHST organizations, whose instructors are prepared through a Train-the-Trainer model program, offering hazardous materials instruction in nearly all states of the nation. CCCHST instructors, prepared and supported by PETE, will annually train a minimum 40,000 students, workers, and supervisors to protect themselves and their communities from exposure to hazardous materials encountered during hazardous waste site cleanup, Brownfields redevelopment, transportation of hazardous materials, and response to spills and releases of hazardous materials, offering a minimum 300,000 contact hours of instruction each year. Each year, PETE and Eastern Iowa Community Colleges (EICC), or another qualified CCCHST institution, will provide an intensive 5.5-day, hands-on Great Environmental Safety Trainers (GreatEST) Train-the-Trainer Institute for up to 20 instructors entering membership in CCCHST, supplemented with Internet-supported instructor training and a virtual waste site; an optional 2.5-day face-to-face Industrial Emergency Spill Response Train-the-Trainer; annual StayFresher training via Zoom for all members, and a 2.5 day annual Conference for 50 CCCHST members. PETE and Barton Community College, KS, will also provide direct worker training for a minimum 600 Total Military Family personnel at three Midwest bases annually, Fort Riley (KS), Fort Sill (OK), Fort Carson (CO), and via Zoom nationally and internationally for Veterans, soon-to-retire military personnel or family members who need OSHA certifications to enhance employment opportunities.